DISTRIBUTION OF HEMATOPORPHYRIN DERIVATIVE IN BARRETT'S ESOPHAGUS

The purpose of this study is to determine if determining drug concentrations will aid in predicting possible response of Barrett's esophagus to photodynamic therapy.